HPA AXIS/DOPAMINE INTERACTIONS IN PSYCHOTIC DEPRESSION

This study attempts to further delineate the relationship between the hypercortisolemic state that characterizes psychotic depression and dopaminergic activity. It is hypothesized that HPA axis overactivity may lead to dopaminergic overactivity resulting in psychotic symptoms. In this study, the HPA axis is evaluated using CRH and hydrocortisone as probes for discerning the difference between healthy controls and patients with major depression, with and without psychotic symptoms. Measures of dopamine activity are evaluated in response to these challenge probes. This study began in early 1995 and continues. We have collected data on 34 controls, 42 depressed patients, and 13 psychotically depressed patients. Of these 89 patients, 59 have been studied at Stanford and 30 at the East Coast site (previously the Brigham and Women's Hospital, Boston, now the Metropolitan St. Louis Psychiatric Center, St. Louis).